Control mechanisms of 5-hydroxymethylcytosine metabolism in human cells

Project Summary
The 5-hydroxymethylcytosine (5hmC) in mammalian DNA is drawing significant attention in epigenetics
because of its indispensable roles in gene expression regulation. The loss of 5hmCs in various cancers
including glioblastomas and lymphomas has been linked to the poor survival rate as well as the resistance to
anti-cancer therapeutics. Although there is amassing evidence of 5hmCs as a novel epigenetic marker, there is
very little understanding on how 5hmCs are enriched at specific loci in the genome. In this project, we aim to
identify the factors controlling the DNA demethylation pathway, which result in the formation of locus-specific
5hmCs in human neurons. For this purpose, proteins controlling the activity of ten-eleven translocase (TET)
family enzymes in the DNA demethylation pathway will be identified. To examine the function of candidate
proteins, we will take advantage of human induced-neurons (hiNs) derived from human induced-pluripotent
stem cells (hiPSCs). In addition, we will elucidate the role and fate of 5hmCs formed during DNA damage
repair process using blue light-inducible CRISPR/Cas9 technique. This robust experimental platform will
enable the rapid production of isogenic and homogenous neurons and other cell types. With this cell-based
assay system, high-throughput assays can be developed that will advance biomedical researches and drug
discoveries. Finally, we expect the successful completion of this project will expand our understanding on DNA
demethylation and their roles in epigenetics, development, and various human diseases.

Public health relevance
Project Narrative The fate and function of cells, tissues, organs, and organisms are determined by the expression of specific set of genes in the genome. This project aims to pinpoint the mechanism controlling DNA demethylation which is the principal means of gene expression regulation and genome stability. The outcome of this project will shed light on DNA methylation-specific regulation of gene expression and DNA damage repair in human cells and may have broader impacts on a variety of human diseases including cancer and neurodegenerative diseases.